IGF::OT::IGF EXTRACTION, TRANSFORMATION AND LOADING (ETL) OF THE SEER BREAST CANCER DATA TO THE OBSERVATIONAL MEDICAL OUTCOMES PARTNERSHIP (OMOP) COMMON DATA MODEL (CDM), IN SUPPORT OF THE NATIONAL CA

SEER Record Linkage Support and Evaluation Services